Sequencing and sample core: genetic errors of immunity

Project Summary—Core A
The exponential growth of next-generation sequencing has revolutionized the study of genetic errors of immunity.
We, as a community, have collectively identified over 500 genetic lesions leading to immune dysregulation
syndromes. These syndromes encompass susceptibility to infections, autoinflammation, autoimmunity, allergy
and cancer. The identification and characterization of genetic lesions is paving the way for the use of
personalized medicine and the study of rare genetic syndromes. Despite the tremendous success achieved, the
genetic cause of the disease remains to be identified in over 70% of families. Furthermore, even when a genetic
lesion is identified, it may not segregate perfectly with the disease. Thus, some individuals carrying the mutation
are very ill, whereas others display little or no clinical disease (low clinical penetrance of the disease). Both of
these problems — the absence of a known genetic cause of disease and variable disease penetrance — require
further investigation. We now have opportunities to study samples from human subjects with an unprecedented
degree of granularity, and advances in next-generation sequencing are making it possible to decipher
increasingly complex datasets for genetic and molecular signatures. These samples were obtained from human
subjects with unknown genetic lesions or known genetic lesions, from families in which clinical disease has
incomplete penetrance. The human sequencing and sample core will streamline the datasets available for all
enrolled patients and their families, by storing samples, sequencing (DNA and RNA) in bulk and at single-cell
levels at typical and extraordinary depths, and will store the sequencing results, sharing these data with the
bioinformatics core and associated projects. By reducing barriers and uniformizing data from different sources
in our shared approaches it should be possible to increase the efficiency of data collection and downstream
analyses for all P01 projects.